Validation of a lab-free low-cost screening test for prevention of cervical cancer: automated visual evaluation

PROJECT SUMMARY/ABSTRACT
Artificial intelligence (AI) has the potential to revolutionize medicine by improving productivity, reducing human
error, and assisting with diagnosis and treatment. Image classification algorithms can be used to develop
automated visual evaluation (AVE): a potential game-changer for cervical cancer prevention in low- and
middle-income countries (LMICs). AVE technology reads digital photographs of a cervix to provide diagnosis
and treatment recommendations in seconds. AVE is a true point of care test, low cost and does not require a
laboratory. AVE could be used either for stand-alone primary screening, or to triage HPV-positive women. We
will compare AVE to common screening methods in LMICs: visual inspection with acetic acid (VIA) and
conventional cytology. Enhanced Visual Assessment (EVA) System by MobileODT is a cloud-connected
mobile colposcope on a smartphone platform. It is FDA cleared and used in 42 countries. MobileODT is
uniquely poised to integrate AVE into the EVA System.
Our aim is to validate and commercialize AVE on the EVA platform. Phase I aims will adapt AVE to run on the
EVA system using an optimal neural network architecture, running either directly on the phone or as a cloud-
based service. Phase II is a prospective clinical trial of 10,000 patients recruited at ministry of health sites in El
Salvador. All screen-positive patients, and 10% of negative patients, will undergo colposcopy with biopsy.
Sensitivity of AVE as a primary screening test will be compared to cytology and to VIA. In HPV-positive
women, AVE will be compared to VIA as a triage test.

Public health relevance
PROJECT NARRATIVE The proposal involves developing and testing a cervical cancer screening test: automated visual evaluation (AVE) based on an image classification algorithm that runs on smartphone-based colposcope. Included are both technical development to integrate AVE to a mobile phone application (Phase I), and a prospective validation on a screening population of 10,000 women in El Salvador (Phase II). AVE will be compared to standard tests (conventional cytology and visual inspection with acetic acid: VIA) for primary screening, and against VIA triage in an HPV+ population.